Understanding the developmental xenobarrier

The goal of this research is to identify immunological and developmental barriers that limit interspecies chimera
formation, with the long-term aim of identifying robust and ethically-acceptable approaches to generate human
organs for clinical transplantation. Generation of human organs on-demand would compensate for the chronic
shortage of organ donors. However, in vitro generation of whole organs has proved difficult. To address this
issue, my laboratory has demonstrated proof-of-concept for generating functional organs in vivo by repurposing
the “developmental niche” of a host species to grow an organ of a second (donor) species. After injecting mouse
pluripotent stem cells (PSCs) into Pdx1-/- (pancreatogenesis-deficient) rat blastocysts, the mouse cells
complemented the empty organ niche and developed a mouse pancreas in a rat. Highlighting the therapeutic
potential of this approach, islets prepared from this mouse pancreas could maintain normal blood glucose levels
in diabetic mice following transplantation. Transplanting such genetically-matched organs would bypass the
detrimental requirement for life-long immunosuppression. While interspecies organogenesis has the potential to
solve the organ-donor shortage, several ethical and practical issues must be addressed before we can move to
studies involving human organogenesis in animals. In this proposal, we aim to tackle two key issues by studying
interspecies rodent chimeras. The first issue is that donor engraftment rates in interspecies chimeras are often
low, regionally variable, and lead to embryonic lethality. We hypothesize that the existence of a xenogenic barrier
limits interspecies engraftment and development. Loss of donor engraftment often occurs concomitantly with
formation of the immune system, suggesting an immunological component of the xenobarrier. By identifying and
modulating constituents of this xenobarrier, we aim to develop strategies to improve interspecies organ
generation. The second issue is an ethical concern regarding generation of systemic chimeras in which human
PSCs could contribute to the brain (ectoderm) or germ cells of other animals. We hypothesize that these current
roadblocks can be overcome by using lineage-committed progenitor cells that have lost the developmental
potential to generate brain or germ cells. Additionally, limiting chimerism to a specific region may overcome the
lethal effects of systemic engraftment while allowing high levels of regional chimerism. My laboratory has already
demonstrated proof-of-concept for the use of lineage-committed endodermal progenitors in an intraspecies
context. Endodermal progenitors can only contribute to endodermal tissues (e.g. pancreas), affording a
“targeted” chimerism approach. Here, we will explore the plasticity and limits of heterochronic progenitor
engraftment and aim to validate interspecies targeted organogenesis in mouse-rat and human-rat chimeras. In
summary, by applying the above advances to investigate the biology of interspecies organogenesis, we will
develop robust strategies for ethically-acceptable human organ generation.

Public health relevance
NARRATIVE While interspecies chimeras could be used to generate functional human organs needed for clinical transplantation, this approach currently has both practical and ethical barriers. By studying the biology of interspecies rat chimeras, our research aims to solve two key roadblocks in the development of this approach: the low engraftment rates in interspecies chimeras and the ethically-unacceptable systemic contribution of donor cells to unintended regions (e.g., brain and germ cells). Overcoming these barriers will enable us to develop an efficient and ethically-responsible interspecies targeted organogenesis approach, and ultimately generate functional pancreata that can cure diabetes.